Patterns of HIV, hepatitis C, and sexually transmitted infections (STI) co-infection among rural people who inject drugs in the context of an ongoing HIV outbreak

PROJECT SUMMARY
Cabell County, West Virginia has been experiencing an ongoing HIV outbreak linked to injection
drug use since 2018 among people who inject drugs (PWID), driven by both syringe sharing and
unprotected sex. Little attention has been paid to other infectious diseases that share
transmission pathways in the context of this outbreak. Thus, we propose to examine HIV,
Hepatitis C, syphilis, gonorrhea, and chlamydia co-infection patterns, identify correlates of co-
infection (Aim 1), and assess associations with health-related quality of life (Aim 2) among an
existing cohort of 400 rural PWID in Cabell County. We will further explore the decision-making
processes of PWID who engage in risk behaviors with known HIV+ partners to identify
psychosocial targets for future interventions to prevent infectious disease transmission (Aim 3).
To achieve the study goals, we propose conduct Hepatitis C and STI (syphilis, gonorrhea, and
chlamydia) testing at the 9 and 12 month follow up visits of the HEARTS of WV study
(R01DA059335) to supplement existing HIV testing procedures. We will then conduct a latent
class analysis of co-infection profiles using the infectious disease testing results. We will
conduct a latent class regression analysis to assess sociodemographic, behavioral, and social
network correlates of co-infection profiles. We will then use structural equation modeling to
estimate the total, direct, and indirect effects through infectious disease treatment engagement
on health-related quality of life. We will then conduct 30 in-depth qualitative interviews with
PWID who report engaging in syringe sharing or unprotected sex with known HIV+ partners
around their decision making processes for doing so to identify modifiable influences to inform
future intervention. This proposal will address key gaps in the existing literature by approaching
co-infection holistically among PWID, as most co-infection research to date has focused on a
single disease parings or transmission pathway (e.g., sexual risk). Findings from Aim 3 in depth
interviews will be used to inform future intervention development and implementation by our
local partners at the Cabell Huntington Health Department to reduce disease spread.
Importantly, the study activities will all occur within the context of an active HIV outbreak which
are increasingly common occurrence in rural communities due to the ongoing opioid crisis,
making this a high priority context to study to inform future response strategies.

Public health relevance
PROJECT NARRATIVE This project will examine HIV, Hepatitis C, syphilis, gonorrhea, and chlamydia co-infection patterns, identify correlates of co-infection, and assess associations with health-related quality of life among an existing cohort of 400 rural PWID in Cabell County during an active HIV outbreak. We will also explore the decision-making processes of PWID who engage in syringe sharing and/or unprotected sex with known HIV+ partners through 30 in-depth interviews to identify psychosocial targets for future interventions to modify behaviors and prevent infectious disease transmission. Findings from this study will be used to inform future intervention development and implementation by our local partners at the Cabell Huntington Health Department to reduce disease spread.